Maternal-Fetal Medicine Units (MFMU) Network

Abstract/Project Summary:
The Maternal Fetal Medicine Network is one of the première groups of clinical investigators in the country. The
Columbia Center has been privileged to be a member of this research collaborative for over 19 years and is now
submitting a limited competition continuation application to complete the current ongoing studies. The Columbia
Center is composed of 5 large perinatal centers working together under a single administrative structure
administered by Columbia University. The centers have a long and successful history of collaborative multi-
centered research. During the last current cycle of the MFMU, the Columbia Center has ranked near the top in
recruitment. Columbia Center faculty have designed and led major trials, performed ancillary studies and
secondary analysis, served on subcommittees, and successfully presented concepts. Our faculty currently lead
4 of 9 ongoing MFMU protocols. The Columbia Center provides approximately 26,000 deliveries per year of
which over 30% are high risk; has 43 MFM physicians, several of which have the protected time and expertise
to be involved in Network activities; has tertiary level NICUs with neonatologists experienced in Network studies;
well established infant follow-up programs; has a robust genetics program with 13 board certified clinical, cyto
or molecular geneticists; and over 40 nurses, recruiters and staff dedicated to network activities.

Public health relevance
Project Narrative Reducing perinatal and infant morbidity and mortality and eliminating health disparities are important in improving the long term health of our country. By performing large prospective trials, health services research, and studies of cutting edge technologies, the Columbia Center of the MFMU Network has been a leader in better understanding the underlying causes of these morbidities and in designing and testing treatments to reduce them.